Applied Research

Project Summary – Applied Research Component
This project supports continued funding for the National Xenopus Resource (NXR) located at the Marine
Biological Laboratory in Woods Hole, MA. In this applied research component, we propose to continue our work
on improving cryopreservation of Xenopus sperm. Many researchers are unable to maintain several different
strains in their colony and rely on the use of cryopreserved sperm to be able to generate different transgenic
embryos for their research. Although we have a method for cryopreserving sperm, it is not reliable and often we
must repeat the procedure if the cryo sperm does not work well. We are also attempting to use French straws
instead of vials as they provide a greater surface area and smaller footprint.